PRODUCTION ASSISTANCE FOR CELLULAR THERAPIES (PACT)- CELL PROCESSING FACILITIES CELL MANUFACTURING AND PROCESS DEVELOPMENT SERVICES FOR PCT009-02: MANUFACTURE AND TEST IPSC CARDIOMYOCYTE BANKS

The goal of this project is to manufacture and test cGMP master and working iPS cell banks and subsequently iPSC differentiated cardiomyocytes for use in Avery’s engineered cardiac tissue.